IMPROVE ANIMAL RESOURCES CENTER FOR BIOMEDICAL RESEARCH

The primary objective of this project is to provide the Animal Resources Center the capacity to enable St. Jude investigators to conduct their animal-related projects in an environment that will assure their achieving the goals of the institution, to determine the etiology and the means for prevention and treatments of childhood cancers. The specific aims are to enable to Animal Resources Center (1) to meet the present requirements of the SJCRH investigators that use the ARC, (2) to provide for more effective utilization of the ARC and its personnel, (3) to assure continued accreditation by the American Association for Accreditation of Laboratory Animal Care (AAALAC), and (4) to assure the institution's animal related projects will continue unhampered during and after the completion of the institution's present growth phase.